Genetic, Metabolic and Regulatory Control of MIC and Relapse in M. tuberculosis

ABSTRACT
TB treatment is an enigma of ineffectiveness. Current TB chemotherapy rapidly kills nearly all bacteria within
two weeks, yet tolerable treatment failure rates are only achieved after 6 months, and even then, ~5% of cases
relapse. Our recent work shows that bacterial factors associated with small MIC shifts are important predictors
of treatment outcome, but the driving forces behind those shifts are unknown. This project unites three labs,
with highly complementary expertise, around interrogating carefully curated M. tuberculosis clinical isolates
with leading edge approaches in genetics, metabolism, gene regulation and network-based modeling to reveal
fundamental new knowledge about how TB responds to front-line drugs. The direct result of this effort will be a
suite of candidate biomarkers with great potential to personalize treatment duration by predicting treatment
outcome and greatly simplify TB drug trials, as well as novel drug targets to improve outcomes and shorten
therapy. These translational aims will be pursued in future studies, using the insights, strains and tools
developed in the program.

Public health relevance
NARRATIVE We recently discovered that small differences in bacterial susceptibility to TB drugs are important predictors of treatment outcome, but what drives those differences is not known. This project unites three labs with highly complementary expertise to interrogate how M. tuberculosis clinical strains respond to treatment. We will apply with leading edge approaches in genetics, metabolism, gene regulation and network-based modeling to reveal fundamental new knowledge about TB that could lead directly to shorter treatment times and better treatment outcomes.